ShEEP request for next generation sequencing system

The requested sequencing equipment is state-of-the-art sequencing machine, versatile, and will be used by all funded VA investigators at the VABHS. This is Illumina NextSeq-550 Sequencing System with 10X genomics controller to make single-cell-libraries. Our researchers at VABHS investigate diverse fields of research including cancer (myeloma & colorectal) and neuroscience (Alzheimer's, sleep, CTE, TBI & PTSD) as well as other fields of research (kidney, spinal cord, stem cells, coagulation, & alcoholism) that are aimed at aiding veterans. Currently, VA-funded projects have specifically outlined procedures using NGS sequencing and microarray scanning instruments, but they must use non-VA facilities to perform their VA research. We describe that VA investigators do not currently have the requested sequencing equipment at any VABHS research facility is a major need for this equipment. The equipment will also allow for exciting new developments for VA investigators research projects and give new opportunities for collaborations between VA and non-VA investigators. Obtaining this equipment can also strengthen new funding proposals and lead to collaborations including those that will complement genetic wide-association studies such as the Million Veteran Program. Lastly, having this equipment on site will allow us to attract and retain the best possible basic and clinical scientific talent in the world on topics that will serve our veterans. Drs. Zielinski and Prabhala will be responsible for being fully informed of the equipment operation and maintenance and will ensure that users are trained in flow cell cleaning and general- purpose cleaning.

Public health relevance
The requested new sequencing system will be useful to identify molecular targets at genomic level and will be used by all funded VA investigators at the VABHS. The new molecular targets obtained by VA researchers and clinicians are aimed to improve veterans' health. Obtaining this equipment can also strengthen new funding proposals and lead to collaborations including those that will complement genetic wide-association studies such as the Million Veteran Program.